Core A- Administrative Core

Abstract
Core A will provide the administrative support for the Program Project and thus serves all three Projects
and the other two Cores. Specifically, the core will provide the interface between the Program Project, the
Lerner Research Institute of the Cleveland Clinic, University Hospitals, and Case Western Reserve School
of Medicine, where all investigators are located. In this capacity, the Core will help ensure that institutional
compliance deadlines are met in a timely fashion, such as the filing human subject and animal research
protocols. The Core will also provide the interface between the Program Project and NIH by seeing that
Progress Reports and other correspondences are organized and submitted in a timely fashion. The Core
will have an advisory board comprosed members from within the Cleveland Clinic, University Hospitals,
and Case Western Reserve School of Medicine (Internal Advisory Board) ,and of distinguished scientists
from outside the institutions (External Advisory Board) to provide guidance, critical assessment and advise
to each of the three projects. Core A will also handle travel arrangements to bring for speakers, organize
meetings of the Program Project, and oversee the fiscal management of the Program Project. Core A will
be directed by Dr. Edward Plow, the PI of the program project. Dr. Plow is also head of the Center for
Thrombosis and Vascular Biology. He has initiated this exciting Project and has served as a SCCOR PI,
as a Principal Investigator of a Program Project, and as a Project Leader of two other PPGs. He was a
member of External Advisory Boards for two other Program Projects. These roles have provided him with
the administrative experience to direct this core.